Individuals' Longitudinal Risks for Firearm Violence Perpetration and Victimization

PROJECT SUMMARY
This K18 Career Enhancement Award will provide 2-years protected time for Dr. Christopher Morrison (Assistant
Professor of Epidemiology, Columbia University) to become a leader in applied prevention science, with new
content-area expertise in firearm injury prevention. A program of collaboration with four new senior colleagues,
coursework, and research will allow him to accomplish three Training Objectives—A) to develop comprehensive
skills in leadership in firearm violence prevention research and policy; B) to develop comprehensive skills in
designing and implementing cohort studies; and C) to develop comprehensive skills in community engagement
for firearm violence prevention. Dr. Morrison will accomplish this training in the Department of Epidemiology at
Columbia University with a Visiting Scholar position at the Yale New Haven Hospital—Violence Intervention
Program (YNHH-VIP). This training is tailored specifically to develop expertise necessary to advance the science
of firearm violence prevention, including by leading the development of protocol for a multi-site prospective cohort
study for people at risk of experiencing firearm violence. Preventing firearm violence is a high priority for
research, but data are sparse. A social ecological systems framework provides a theoretical basis for
understanding the complex processes that contribute to individuals’ risks for firearm violence victimization and
perpetration, and emphasizes that contributors to firearm violence operate at multiple scales of organization
(e.g., individuals, households, neighborhoods, cities, states) and over the lifecourse. To examine these complex
processes we require longitudinal data collected at the individual level over many years, including detailed
measurement of outcomes and theoretically relevant exposures related to firearm violence. We will use data
from the National Longitudinal Study of Adolescent to Adult Health (Add Health), which is the largest longitudinal
study in the US that includes measures of firearm violence perpetration and victimization, as well as critical
contextual measures that are theoretically relevant for firearm violence prevention over the lifecourse. The
specific aims are: 1) To assess longitudinal relationships between social ecological exposures during
adolescence and trajectories of firearm violence perpetration into adulthood; 2) To assess longitudinal
relationships between social ecological exposures and nonfatal firearm violence victimization over the lifecourse;
and 3) To assess longitudinal relationships between social ecological exposures during adolescence and fatal
firearm violence victimization into adulthood. Research activities will complement the collaboration and
coursework portions of the proposed career development plan, provide ideal opportunities to apply new skills,
and ultimately consolidate the candidate as a leading prevention scientist conducting high-impact studies,
including expanding available interventions to reduce firearm violence.

Public health relevance
PROJECT NARRATIVE Dr. Christopher Morrison is a mid-career researcher who specializes in spatial epidemiologic studies of environmental strategies to prevent injuries. This K18 Career Enhancement Award will provide protected time to develop new content-area expertise in firearm injury prevention. Dr. Morrison will work with a team of new senior collaborators to conduct analyses of the National Longitudinal Study of Adolescent to Adult Health (Add Health), to identify modifiable predictors of firearm violence and develop interventions to prevent its occurrence.